Faithful Response II: COVID-19 Rapid Test-to-Treat with African American Churches

PROJECT SUMMARY
Many multilayered barriers increase risk for COVID-19 among AA including poverty, essential jobs with
increased virus exposure, cultural norms (eg, risk denial, medical/contact tracing mistrust), chronic health
conditions, and limited access to healthcare and other services/resources. These barriers highlight the need for
accessible, trusted COVID-19 testing and linkage to antiviral treatment and care services (LTC; e.g., health,
prevention programs, community resources, contact tracing) and to community resources (e.g., food, rent
assistance) to help slow COVID-19 spread in AA communities. The AA church is an institution with extensive
influence in AA communities and may be an ideal setting for increasing reach of COVID-19 test-to-treat (TTT)
interventions with LTC in hard hit AA communities. Yet, no controlled AA church-based studies exist on
COVID-19 TTT interventions. The primary aim of this study is to fully test a culturally/religiously-tailored,
church-based COVID-19 TTT with LTC intervention condition against a non-tailored education condition on
COVID-19 rapid testing rates at 6 months with adult AA church members and the community members they
serve. Churches will be matched on membership size, denomination and past participation in church health
intervention studies, then randomized to treatment condition. Twelve churches (6 churches per arm; 55 church
and 20 community members/church; N=900 total) will participate in the study. Antiviral and contact tracing
intentions and use will also be examined at 6 months as secondary outcomes. Other types of COVID-19
testing and linkage to care use will also be assessed. Guided by the Theory of Planned Behavior and
Socioecological Model, our community-engaged approach includes trained church leaders delivering a
culturally, church-appropriate COVID-19 TTT Toolkit inclusive of digital tools: a) individual self-help materials
and automated/tailored text messages; b) ministry group educational information; c) virtual/in-person church
services with COVID-19 related materials/activities (e.g., sermons, pastors modeling rapid-self testing,
testimonials, bulletins); and d) church-community level linkage to care (LTC) services (e.g., contact tracing,
treatment, healthcare, community resources) provided by contact tracers serving as community health workers
(CHW). Intervention churches will host 2 COVID-19 TTT events and will also provide members with take-home
COVID-19 rapid self-test kits. Potential mediators/moderators related to receipt of COVID-19 testing will be
evaluated, and a process evaluation to determine implementation facilitators, barriers, and fidelity related to
increasing COVID19 testing rates. Our ongoing meetings with our long-term faith and health partners is
enabling us to quickly adapt our AA church-based COVID-19 testing, HIV testing and diabetes prevention
interventions for the proposed study. This novel study is the first to fully test a COVID-19 TTT intervention in
AA churches. It could provide a theory-based, multilevel scalable model for equipping AA churches to deliver
wide-reaching COVID-19 rapid testing and promote treatment with health agency partners.

Public health relevance
PROJECT NARRATIVE This 2-arm clustered, randomized community trial will test a multilevel, religiously-tailored COVID-19 rapid, self-testing and treatment intervention against a nontailored, education condition on uptake of COVID-19 rapid testing with 900 adult African American church members and community members using outreach ministry services from 12 churches at 6 months. Rapid COVID-19 self-testing and contact tracing (beliefs and practices), and use of linkage to care services (e.g., referrals to treatment, health insurance, medical home/appointments, community resources) will also be examined. Findings from this study could provide a scalable model for feasible, accessible and acceptable COVID-19 rapid, self-testing (with rapid linkage to treatment and health/community resources) in public (churches and their affiliate settings and organizations), home, and health provider spaces by equipping African American churches with culturally-appropriate, easy-to- use rapid test kits, health department support, and tailored COVID-19 TTT education and promotion tools.